Activation of transposable elements as an endogenous source of neoepitopes and mediators of tumor immunogenicity

1 PROJECT SUMMARY/ABSTRACT
2 Candidate Background: I received my Ph.D. from the Autonomous University of Madrid with Dr. Mercedes Robledo,
3 focusing on genomic characterization of pheochromocytoma. My postdoctoral research studies with Dr. WK Rathmell at
4 Vanderbilt University with a focus epigenetic factors in the development and progression of renal cancer.
5 Career Goals and Objectives: My career goal is to become an independent, tenure-track faculty member at a high-caliber
6 research institution, working with an interdisciplinary team, and focusing on identifying new therapies for kidney cancer.
7 Career Development and Training Activities: My training plan revolves around mentorship, didactic training, and
8 protected research time to support my transition to independence. Dr. WK Rathmell will serve as my primary mentor; she
9 will train me in laboratory and personnel management, grant administration, and translational kidney cancer research. Dr.
10 Jeff Rathmell will provide mentorship in tumor microenvironment, and Dr. Gyan Bhanot will provide mentorship in
11 computational biology. I will attend selected seminars and workshops, and continue responsible conduct in research training.
12 Significance and Innovation: Although immune checkpoint blockade (ICB) has shown remarkable success in treating
13 metastatic kidney cancer (RCC), not all patients respond to therapy. We recently reported that high expression of
14 endogenous retroviruses, a class of transposable element (TE), occurs in a subset of RCC tumors and can predict response
15 to ICB in RCC. Mobile genomic elements, TEs are usually suppressed by a number of epigenetic mechanisms. Aberrant
16 expression of TEs can activate host antiviral responses and produce neoantigens, and in some RCCs, activate antiviral response
17 that results in increased immunogenicity, characterized by increased immune infiltrate. Thus, it is our premise that epigenetic
18 modulation of TE expression represents a novel therapeutic strategy to enhance response to ICB in RCC and other cancers.
19 Approach: Based evidence to date, I hypothesize 1) that epigenetic activation of TEs enhances neoantigen production to
20 contribute to immunogenicity in RCC, and 2) that additional epigenetic mechanisms exist that regulate TE activity and that
21 these can be manipulated to promote immunogenicity.
22 Specific Aim 1: Define the role that epigenetic activation of transposable elements has in neoepitope production. 1A)
23 Interrogate transcriptional landscapes associated with epigenetic activation of TEs. 1B) Identify naturally processed TE-
24 associated neoepitopes.
25 Specific Aim 2: Define additional epigenetic mechanisms governing TE expression. 2A) Define epigenetic mechanisms
26 mediating TE suppression. 2B) Determine how epigenetic activation of TEs mediate host antiviral response. 2C) Elucidate
27 mechanisms behind TE-induced IFN signaling.
28 Transition to Independence: I will apply to faculty positions during the Mentored phase and accepting a tenure track
29 position to transition to the Independent phase. My goal is to characterize novel mechanisms for TE-associated antitumor
30 immunity and identify novel targets regulating TEs. These studies will serve as the basis for an NCI R01 application.

Public health relevance
PROJECT NARRATIVE This K01 NCI Mentored Research Scientist Development Award to Promote Diversity proposal will explore epigenetic therapies to activate transposable elements (TEs) to promote neoepitope presentation, and will identify and characterize additional epigenetic mechanisms regulating TE expression to identify potential novel therapeutic targets. The training plan is designed to prepare me for a career in translational cancer research by providing additional coursework in advanced genomics, proteomics, and immunology, training in laboratory management, grant administration, and mentored experiences with my committee of expert mentors.